Center for Improving Care Delivery for the Aging (CICADA)

REVISED Project Summary – Leadership and Administrative Core
This proposed renewal of the Resource Center for Minority Aging Research (RCMAR) at the University of Pennsylvania (Penn)—the Center for Improving Care Delivery for the Aging (CICADA)—aims to train emerging scientists in the interdisciplinary science of health services research (HSR), an interdisciplinary scientific field focused on improving organization, management, financing, and delivery of high-quality care and improving health. Over the initial funding cycle, CICADA’s Leadership and Administrative Core (LAC) has united and led a team of experts to achieve the Center’s overall aims: (1) to enhance the aging-focused research workforce by mentoring promising scientists for careers dedicated to improving health care delivery and health for older adults and (2) to develop and sustain infrastructure to promote science that improves the health, wellbeing, function, and independence of older adults through transformation in health care delivery. To accomplish this, the LAC will continue to oversee the Center’s Research Education Component (REC) and Analysis Core, and to ensure that we achieve the Specific Aims of each core. The LAC will work closely with the leaders of these three components (CICADA’s “core faculty”), who comprise the Center’s Executive Committee, to ensure success. The LAC will also continue to work in close partnership with Penn’s institutional partners (through the Internal Advisory Board), and with national experts in aging and equity-integrated HSR (through the External Advisory Board). These groups will meet regularly with CICADA leadership and provide guidance and evaluation of progress toward meeting the overall Aims of the Center. The LAC will also leverage the resources of Penn’s Leonard Davis Institute of Health Economics to ensure the success of CICADA.
In this renewal application, the LAC will build on our prior successes and establish and build on an existing strong relationship between Penn and Meharry Medical College. With Meharry as an additional partner, the LAC will oversee CICADA as it recruits and selects talented scientists and then trains and mentors them during their time with CICADA and beyond, so that they may become future leaders in HSR focused on aging and older U.S. adult populations. The LAC has three Specific Aims (1) To advance CICADA’s goals by overseeing, managing, and coordinating Center activities; (2) To provide leadership to advance discoveries in HSR at Penn, focused on improving health care delivery and health for aging adults (3) To foster and integrate long-term growth into all aspects of the CICADA environment, taking an individualized approach to Scientist mentoring and development.